Novel Reagents for Breast Tumor SPECT Imaging

PROJECT SUMMARY Breast cancer screening using mammograms and other imaging techniques are the first line of defense against the disease as a means to detect pre-cancerous lesions. The diagnostic power of advanced imaging techniques could benefit tremendously from improved contrast agents that rapidly and selectively accumulate in the tumor lesions and provide high tumor-to-normal tissue ratios, as well as minimizing exposure of patients to radiation by lowering injected activity of the reagents. We propose to develop novel contrast agents for use in breast cancer imaging that can enhance image resolution by selectively targeting and delivering imaging probes directly into tumor lesions with little or no accumulation in the surrounding normal tissue. We have developed an antibody-based delivery platform that exploits a caveloae-mediated transvascular transport pathway to target and rapidly deliver cargo across the restrictive vascular endothelium directly into tumor lesions following intravenous injection. We propose to conjugate 99mTc via a chelating moiety to the targeting antibody (mAnnA1) and to test the resulting imaging probe in rodent models that will include induced metastatic and spontaneous breast tumors. We will optimize the imaging protocol by studying biodistribution of the reagent and determine key parameters in order to characterize selectivity and targeting specificity of the novel reagent.

Public health relevance
PROJECT NARRATIVE Cavatar is developing a novel imaging reagent which will rapidly, selectively, and specifically accumulate in tumor lesions after an intravenous injection, providing for enhanced image resolution. This reagent can enable accurate imaging of breast tumor using existing equipment for screening or diagnostic applications. This technology will improve diagnostic accuracy of imaging, allow for more accurate stratification of patients and selection of treatment choices, and reduce the need for performing additional diagnostic procedures.